Evaluating System Change to Advance Learning and Take Evidence to Scale (ESCALATES)

? DESCRIPTION (provided by applicant): A growing literature and our team's extensive experience with primary care practice redesign studies make clear that a practical and effective model for large-scale dissemination and implementation of patient-centered outcomes research evidence is still lacking. The current AHRQ RFAs to fund eight different grants to test specific intervention strategies (RFA-HS-14-008) in 250 practices each plus one

Public health relevance
PUBLIC HEALTH RELEVANCE: Evaluating System Change to Advance Learning and Take Evidence to Scale (ESCALATES) is a study to evaluate the R18s funded by AHRQ through RFA-HS-14-008. In this study, we will engage R18 grantees in the